Synthetic-Lethal-Based Targeted Therapy for Oncogenic KRAS-Driven Cancer

DESCRIPTION (provided by applicant): Despite recent significant advances in molecular targeted cancer therapy, success has remained limited to a small subset of oncogene-addicted tumors. Cancers known to harbor some of the most prevalent oncogenes, such as KRAS, remain refractory to effective treatment. Novel systematic genetic approaches have the potential to identify alternative functional dependencies in cells carrying cancer-causing mutations, a concept known as synthetic lethality. Indeed, through computational analysis of cancer cell-based RNA interference (RNAi) screening datasets, it has been possible to identify and validate both known and novel genetic co- dependencies with common oncogenes such as PIK3CA and KRAS (Vasudevan, Barbie et al., Cancer Cell 2009, PMID: 19573809; Barbie et al., Nature 2009, PMID: 19847166). The goal of this project is to translate these synthetic lethal targets into effective genotype-specific cancer therapy, with a focus on KRAS-driven lung cancer, since it remains an intractable clinical problem. Specifically, the non-canonical I:B kinase TBK1, which is required for survival downstream of KRAS, will be the focus of further mechanistic studies, small molecule screening efforts, and pre-clinical validation. Elucidation of the TBK1-mediated NF-:B survival-signaling pathway will facilitate effective biochemical and cell-based assays for drug development and highlight other potential targets for therapy. Compounds that specifically inhibit TBK1 or other NF-:B signaling components will be characterized for KRAS-selective effects on cell viability in vitro, and then tested for efficacy in mouse model systems. The overall goal of these experiments is to identify effective TBK1/NF-:B small molecule inhibitors that validate in pre-clinical model systems and that can ultimately be evaluated in genotype-directed clinical trials for KRAS-driven lung cancer. Moreover, systematic efforts are currently underway to characterize synthetic lethal targets for a wide array of cancer-related genetic alterations. Effective clinical translation of TBK1 could serve as a model for development of synthetic-lethal-based targeted therapy in cancer in general. This project aligns well with the immediate career goal of applying functional genetic and computational biological approaches to identify novel targets for cancer therapy, and the long-term career goal of translating these findings into effective targeted therapy for KRAS mutant lung cancer. The mentorship of Dr. William Hahn, the resources and collaborative nature of the Broad Institute, and the expert clinical training in the MGH Thoracic Oncology division collectively provide an ideal environment to support career development and the achievement of these goals.

Public health relevance
PUBLIC HEALTH RELEVANCE: Similar to a car with a jammed accelerator, cancer cells are caught in a precarious balance by the oncogenes that push them to divide. Rather than targeting the accelerator directly, it may be possible to tip cancer cells over the edge by instead going after the adaptations that keep them on the road. Targeting these alternative vulnerabilities with effective drugs may lead to new ways to kill cancer cells, while sparing normal cells. Project Narrative Similar to a car with a jammed accelerator, cancer cells are caught in a precarious balance by the oncogenes that push them to divide. Rather than targeting the accelerator directly, it may be possible to tip cancer cells over the edge by instead going after the adaptations that keep them on the road. Targeting these alternative vulnerabilities with effective drugs may lead to new ways to kill cancer cells, while sparing normal cells. __SpecificAimsTextDelimiter__ 10. Specific Aims Although exploiting "oncogene addiction" has led to targeted therapy in specific cancer subtypes, instances of success remain limited and are rarely associated with cure. However, oncogenes may also create alternative genetic dependencies that are vulnerable to therapeutic attack. RNA interference (RNAi) has facilitated comprehensive loss-of-function screens in human cells, providing the opportunity to identify genetic co- dependencies in a systematic fashion. Through combination of large-scale RNAi screening and bioinformatic approaches, we have identified several of these so-called "synthetic lethal" genetic interactions with common oncogenes such as PIK3CA and KRAS1,2. In order to translate these findings into effective targeted therapy, however, it is necessary to determine whether small molecule inhibitors of these genes can recapitulate the synthetic lethal phenotype. The overall hypothesis of this proposal is that small molecule inhibition of the non-canonical IκB kinase TBK1, a synthetic lethal partner of oncogenic KRAS, can translate into effective targeted therapy for KRAS-driven cancers. Aim#1: Elucidate the TBK1 signaling pathway downstream of oncogenic KRAS. Through genetic and cell biological approaches we have found that TBK1 activates NF-κB survival signaling downstream of oncogenic KRAS2. We showed that the synthetic lethal relationship between KRAS and TBK1 involves activation of the NF-κB transcription factor cRel and expression one of its known anti-apoptotic target genes BCL-XL. However, a more detailed understanding of the survival signaling pathway activated by TBK1 is necessary to identify key substrates for use in biochemical assays, robust markers of TBK1 activation, and other potential therapeutic targets within the pathway. Thus, the goal of this aim is to characterize KRAS-TBK1 signaling in detail as a means of facilitating translational studies. Aim#2: Develop small molecule inhibitors of TBK1. The goal of this aim is to develop a robust biochemical assay and a cell-based readout of TBK1 activity in order to screen for small molecules that inhibit TBK1 function. Initial biochemical assay development will make use of a peptide substrate of TBK1 and its related family member IKKε recently identified by my mentor's laboratory. Cell-based assays of KRAS-dependent lethality and TBK1 activity will then be used to determine the efficacy of specific inhibitors in vitro. Furthermore, structure-activity relationships will be utilized to optimize potency and selectivity of candidate compounds. The identification of specific TBK1 inhibitors will allow us to evaluate small molecule synthetic lethality with oncogenic KRAS and provide candidates for further pre-clinical testing. Aim#3: Evaluate effective TBK1/NF-κB pathway inhibitors in mouse models of KRAS-driven cancer. In order to validate candidate small molecule TBK1 inhibitors in vivo, it will first be necessary to evaluate efficacy in tumor xenograft experiments using KRAS-dependent cell lines. I have demonstrated that TBK1 suppression impairs tumor formation in this context, and plan to test the effects of TBK1 suppression in established tumors using inducible shRNA constructs and small molecule inhibitors. Interestingly, in parallel with our work it was also recently shown that inhibition of NF-κB activity in vivo impaired tumor growth in a KRAS-driven murine model of lung cancer3. Thus, small molecule TBK1 inhibitors, as well as potential inhibitors of NF-κB targets downstream of TBK1, will be tested in these mouse models with the overall goal of identifying drugs with therapeutic potential in KRAS-driven cancer.